Neural Mechanisms of Individual Differences in Cocaine Avoidance

Abstract:
Drugs of abuse, such as cocaine, produce rewarding effects that have been extensively investigated. However,
these drugs also produce aversive effects that are far less understood, even though they strongly influence
drug‐seeking, and exhibit large individual variability that contributes to differences in individual addiction
propensity. We found that aversive responses to cocaine depend critically on serotonin and glutamate
signaling in the rostromedial tegmental nucleus (RMTg), a major afferent to midbrain dopamine neurons. This
proposal examines cellular mechanisms by which these receptors drive neural activation and aversive
conditioning, and why these responses occur much more strongly in some individuals than others, with an
overall aim of identifying novel potential therapeutic targets for regulating drug‐seeking and treating
addiction.

Public health relevance
Relevance: Most individuals exposed to cocaine and other drugs of abuse do not progress to dependence, possibly due to individual differences in sensitivity to cocaine's aversive effects, which are much less understood than its rewarding effects, but which we posit depend on specific molecular targets in the rostromedial tegmental nucleus (RMTg) that may provide novel therapeutic targets for addiction treatment.